Salmonella Host interactions

ABSTRACT
Typhoid fever, caused by Salmonella enterica serovar (S.) Typhi, is a major human
disease responsible for 21.6 million illnesses annually. The emergence of extensively drug-
resistant S. Typhi strains in 2016 represents a serious threat to human health according to the
Centers for Disease Control and Prevention (CDC). However, virulence strategies of this
pathogen remain incompletely understood due to the lack of suitable animal models for the strictly
human-adapted S. Typhi. S. Typhimurium infection of mice is commonly used to model the
pathogenesis of typhoid fever. A limitation of this approach is that S. Typhimurium does not cause
typhoid fever in humans, but rather causes a localized gastroenteritis. As a result, virulence
mechanisms that set typhoidal Salmonella serovars, such as S. Typhi, apart from non-typhoidal
Salmonella serovars, such as S. Typhimurium, remain understudied. Experiments proposed in
this application are aimed at addressing this important gap in knowledge. The objectives of this
application are to study the contribution of the virulence associated (Vi) capsular polysaccharide
and the type III secretion system encoded by Salmonella pathogenicity island 2 (T3SS-2) to S.
Typhi infection. Our central hypothesis is that S. Typhi uses the Vi capsular polysaccharide to
disseminate from the gut by evading neutrophil phagocytosis and persists in tissue by using
T3SS-2 to induce a cycle of neutrophil efferocytosis and macrophage efferocytosis. We will test
different aspects of our hypothesis and accomplish the objectives of this application by pursuing
the following two specific aims: 1. Determine the role of the Vi capsular polysaccharide in
dissemination from the gut. 2. Determine the role of efferocytosis during S. Typhi persistence in
tissue. The proposed work is innovative in that it establishes the first mouse model for oral S.
Typhi infection. It is our expectation that successful completion of the proposed experiments will
establish a new model of S. Typhi pathogenesis to incorporate the complexity of host pathogen
interaction in vivo, which will mark a significant conceptual advance.

Public health relevance
PROJECT NARRATIVE Typhoidal Salmonella serovars cause an estimated 21.6 million cases of typhoid fever each year. Due to the absence of convenient animal models to study the causative agent, Salmonella Typhi, our understanding of typhoid fever pathogenesis is still incomplete. In this application, we develop the first mouse model for oral S. Typhi infection to study how the pathogen uses its virulence factors to disseminate from the gut and survive in tissue.